Improving Shared Decision-Making Surrounding Dysphagia Management for Persons Diagnosed with Amyotrophic Lateral Sclerosis

Project Summary
As many as 92% percent of persons diagnosed with ALS develop swallowing impairments
over the course of the disease, which have been linked to aspiration pneumonia and
malnutrition and have been found to have negative prognostic effects on survival. As a result of
these swallowing impairments, patients are faced with the decision of whether to have a feeding
tube placed or not. For patients diagnosed with ALS and their healthcare providers, decision
making surrounding feeding tube placement has long been a significant challenge for a variety
of reasons including the wide heterogeneity and unpredictability in the timing of the onset and
progression of dysphagia and a lack of understanding of patients’ goals and concerns about
tradeoffs, benefits, and risks of management strategies. Endorsed by the National Institute of
Medicine as a way to improve health care quality, shared decision-making encourages patients
to actively weigh the risks and benefits of a treatment and match them to their personal
preferences. Shared-decision making tools (i.e. decision aids) have been found to increase
patient knowledge about a decision, decrease decisional conflict, positively affect patient-
clinician communication, and increase patient satisfaction with important decisions in many
areas of clinical medicine.8 The primary objective of the proposed study is to develop and test a
decision aid that improves patients’ knowledge about the decision, addresses patient and
caregivers’ goals and concerns surrounding the decision, and improves patient and physician
communication throughout the decision-making process. In aim 1, we will determine patient and
caregiver goals and concerns surrounding feeding tube placement using both qualitative and
survey-based research methods. In specific aims 2 and 3, we will use user-centered and
participatory research strategies to develop and test the feasibility, acceptability, and potential
effectiveness of a personalized decision aid prototype for feeding tube placement decision-
making in patients diagnosed with ALS. These aims are closely matched with a curated set of
training goals and a highly interdisciplinary set of mentors to provide the primary investigator
with the skills needed to successfully transition to research independence upon completion of
the work.

Public health relevance
Project Narrative As many as 92% of patients diagnosed with ALS are faced with the decision to have a feeding tube placed or to continue eating as their primary source of nutrition despite difficulty swallowing. At present, we lack an understanding of patient and caregiver goals and concerns surrounding this decision, and practice patterns surrounding feeding tube placement are highly variable. The primary objective of the proposed study is to develop and test a shared decision- making tool (i.e. decision aid) that improves patients’ knowledge about the decision, addresses patients’ goals and concerns surrounding the decision, and improves patient and healthcare provider communication throughout the decision-making process.